Dissecting mechanisms of gene silencing by the lncRNA Kcnq1ot1 in mouse trophoblast stem cells

ABSTRACT
A conserved long non-coding RNA (lncRNA) called Kcnq1ot1 is essential for proper mammalian development.
Defects in proper gene silencing by Kcnq1ot1 result in Beckwith-Wiedemann syndrome, a birth defect with a
high mortality rate whose prevalence is increased in children conceived by in vitro fertilization. Despite its critical
role in development, the mechanisms that Kcnq1ot1 uses to silence genes remain poorly understood. While it is
known that Kcnq1ot1 silences genes by recruiting histone-modifying enzymes called the Polycomb Repressive
Complexes and G9a, it is not clear how sequence elements in Kcnq1ot1 facilitate these interactions. As one
possible clue, another repressive lncRNA that is essential for development, Xist, has been shown to interact with
RNA-binding proteins (RBPs), that in turn, recruit the Polycomb silencing enzymes. In my own studies, I have
found that many of these same RBPs associate with Kcnq1ot1 at levels significantly higher than with other RNAs
in the transcriptome, implying that they too are important for the function of Kcnq1ot1. The objective of my study
is to further develop the mechanism of Kcnq1ot1 by identifying functional sequence domains in the transcript,
identify the RBPs that bind these regions, and determine their involvement in recruiting the Polycomb and G9a
silencing enzymes. If successful, I hope to not only elucidate the mechanism of Kcnq1ot1, which is conserved
in mice and humans, but further our general understanding of lncRNA function in early development. Long term,
this information could eventually contribute to optimization of in vitro fertilization and discovery of genes
implicated in infertility. The activities I propose will provide me with critical training in RNA biology and genomics,
molecular biology, developmental biology, teaching and mentorship, oral communication skills and networking,
and scientific writing, each of which will be critical for my future career as a principal investigator at a primarily
undergraduate institution.

Public health relevance
PROJECT NARRATIVE Beckwith-Wiedemann syndrome, a fetal overgrowth syndrome with a mortality rate of 21 percent, exhibits an increased prevalence in children conceived by in vitro fertilization, and about 70 percent of cases of Beckwith- Wiedemann syndrome are due to dysregulation of the long non-coding RNA Kcnq1ot1. My project aims to elucidate the mechanism of Kcnq1ot1, and further our understanding of how defects in long non-coding RNA function result in diseases like Beckwith-Wiedemann syndrome. Successful completion of this project will result in a foundation of knowledge that could eventually lead to the optimization of in vitro fertilization and may reveal strategies to attenuate the epigenetic activity of Kcnq1ot1, therapeutically.